Chemistry Track II - Human Food Product Testing

Chemistry Human Food Product Testing Project Abstract The goal of this project is to assist Tennessee's Technical Service Laboratory in maintaining conformance to the current MFRPS program and to adapt to any changes to the MFRPS program may see in the future. The Technical Service Laboratory intends to conduct the proposed work using the equipment and staff outlined in this project. The TSL plans to continue offering current analyses that are accredited under ISO 17025 with the plan of adding more testing options during this cooperative agreement.

Public health relevance
Chemistry Human Food Product Testing Research Narrative The Technical Services Laboratory (TSL) is Tennessee's regulatory lab for human food and is the primary servicing lab for the Tennessee Department of Agriculture's (TDA) MFRPS program. The TSL plans to continue working to maintain conformance to the standards set forth in the current MFRPS program. The work outlined in this project will allow TSL to maintain that conformance and adapt to any changes that may come in the future.